Towards a mechanistic understanding of the role of gut microbiota in postnatal growth impairment

PROJECT SUMMARY
Precision engineering of the gut microbiota requires a mechanistic understanding of how microbes interact with
host physiological pathways in order to produce desired health outcomes. In stunted children, commensal gut
microbes have been correlated with aberrant host inflammation and growth impairment, but mechanisms
underlying these associations are poorly understood. Mouse models have suggested causality, but they fail to
recapitulate the dynamics of the mucosal immune system in humans and the complexity of the human gut
microbiota. This project will interrogate these questions in vivo in a cohort of >1500 children from rural
Bangladesh at risk for stunting, for which biological specimens were collected longitudinally from 0-3 years of
age. Preliminary analysis of 16S rRNA gene sequences from >3700 fecal samples collected from these children
has identified a Bifidobacterium sequence variant that is highly correlated with intestinal inflammation and
subsequent growth faltering. In Aim 1, I will identify strain-specific microbial genes that might mediate these
observed associations. In Aim 2, I will interrogate the mechanistic underpinnings by evaluating microbial small-
molecule metabolites in feces and blood associated with high levels of Bifidobacterium and concurrent gut and/or
systemic inflammation in children 14 months old. In Aim 3, I will use advanced latent variable statistical modeling
to determine the importance of associated groups of microbial (taxonomic, metagenomic, and metabolic) and
host (gut and systemic inflammation) features on future growth faltering. I will also estimate the maximum
achievable improvement in child growth from a theoretical, 100% efficacious microbiota-manipulation
intervention, providing an expected effect size for comparison with other intervention alternatives. This work will
increase our mechanistic understanding of the associations between early life gut microbiota and aberrant
intestinal/systemic inflammation as well as future growth faltering, producing new options for predictably
manipulating the gut microbiota to mitigate adverse health outcomes. The proposed project will provide a
rigorous training experience in the fields of gut microbiota, microbial metabolites, multivariate statistics, and
pediatric gastroenterology under the mentorship of a group of scientific experts, and will equip me with the skills
necessary to become an independent researcher.

Public health relevance
PROJECT NARRATIVE The mechanisms by which some health-associated microbes cause inflammation in the gut are poorly- understood, unlike the case with disease-causing microbes. This study seeks to identify these mechanisms in a cohort of children from rural Bangladesh at risk of undernutrition. This research will shed light on biological pathways to target for future precision engineering of the gut microbiota to mitigate childhood stunting.